Development of a multi-modal targeted nanotherapeutic to prevent restenosis in an atherosclerotic environment

PROJECT SUMMARY
Vascular interventions used to treat severe atherosclerosis often fail due to the development of arterial
restenosis secondary to neointimal hyperplasia. In the United States, the only therapies approved for use in
humans aimed at reducing restenosis are drug-eluting stents and balloons. However, these drug-eluting
devices have proven to be problematic with respect to re-endothelialization, thrombosis, and death, and have
led to the release of FDA warnings in 2019. Thus, there is a great need for new technology that will promote
restoration of a healthy vasculature following revascularization. The overall goal of this proposal is to develop
a novel, targeted, drug-releasing nanotherapeutic that will be administered intravenously yet localize
specifically to the site of injury to prevent neointimal hyperplasia. Dr. Kibbe and Professor Stupp’s laboratories,
through funding from a National Institutes of Health Bioengineering Research Partnership R01, have
developed a highly innovative targeted nanotherapeutic comprised of peptide amphiphile (PA) molecules that
self-assemble into three-dimensional nanofibers and are covalently modified to include a collagen-binding
peptide (CBP) that targets the nanofiber to collagen. Nitric oxide (NO) was incorporated as the therapeutic
given its many vasoprotective properties that promote vascular health and inhibit neointimal hyperplasia. Our
laboratories demonstrated that this NO-releasing targeted nanofiber is biocompatible, specifically targets the
site of vascular injury following tail vein injection and inhibits the development of neointimal hyperplasia at 2
weeks—an effect that remains durable out to 7 months in healthy rats. With the success of these studies, it is
time to advance this research to the next stage required for ultimate clinical translation. In humans, vascular
interventions are performed in the setting of atherosclerosis with its associated oxidative stress. Thus, we aim
to advance the technology platform beyond what we have already developed by incorporating additional
targeting moieties and therapeutics that are sensitive to the atherosclerotic milieu. We hypothesize that our
multi-modal nanotherapeutic will target vascular injury and prevent restenosis at the site of intervention in an
atherosclerotic environment. To investigate this hypothesis, we propose the following specific aims: 1)
Develop and evaluate a targeted nanofiber with specificity for the site of arterial injury in atherosclerotic rat
models; 2) Investigate the safety, efficacy and biodistribution of a multi-modal therapeutic targeted nanofiber
platform at inhibiting neointimal hyperplasia following arterial injury in atherosclerotic rat models; and 3)
Evaluate the safety and efficacy of the multi-modal targeted nanofiber platform at preventing neointimal
hyperplasia and restenosis in a preclinical atherosclerotic swine model of arterial balloon injury. Completion of
these aims will result in the development of a multi-modal targeted therapeutic nanofiber platform that will
prevent restenosis following vascular interventions in an atherosclerotic environment. Further, completion of
these studies will position us to start pre-IND meetings with the FDA to begin first-in-human testing.

Public health relevance
PROJECT NARRATIVE Vascular interventions used to treat severe atherosclerosis often fail due to the development of arterial restenosis secondary to neointimal hyperplasia. The overall goal of this proposal is to develop a novel, targeted, drug-releasing nanotherapeutic that will be administered intravenously yet localize specifically to the site of injury to prevent neointimal hyperplasia following vascular interventions in an atherosclerotic environment. Completion of these studies will position us well to start pre-IND meetings with the FDA to begin first-in-human testing with the ultimate goal to improve human health and disease.